Improving Quality of Life of Prostate Cancer Survivors with Androgen Deficiency

Summary
This application requests close-out funds to enable completion of the trial and
accomplishment of the proposed aims of the project. This planned extension of the trial,
discussed previously on several occasions during the past 2 years with the trial's DSMB
and the program staff, was necessitated because of the nationwide suspension of
clinical research activities in 2020 due to the onset of the COVID-19 pandemic. Even
after the complete suspension of non-Covid clinical research activities was lifted, the
subsequent ramp up of clinical research activities in 2020 and 2021 was substantially
slower than in the pre-pandemic period due to the COVID-related restrictions and other
reasons that are described in the Research Strategies section. These COVID-related
constraints substantially slowed participant enrollment and delayed the completion of
the trial. With the gradual lifting of these Covid-related restrictions during the past year,
and a number of steps implemented by the study team that are described in the
Research Strategies section, including the addition of a second trial site at the Brady
Urology Center at the Johns Hopkin Medical Institutions; increased personnel effort for
participant screening; and some DSMB-recommended revisions of eligibility criteria, the
enrollment in the trial has increased substantially averaging 6 randomizations each
month during the past several months. As described in the Research Strategies section,
61 participants had been enrolled as of December 31, 2022, including 23 in the past 4
months. We anticipate enrolling 85 subjects by the end of the current funding period
(April 30, 2023) and completing the enrollment during the extension period. The close-
out funds are requested for completing the planned recruitment in the trial and
accomplishing the approved aims of this project. There was saving of costs associated
with laboratory tests, procedures, and subject payments; these savings will be carried
forward and no additional funds have been requested for these activities.

Public health relevance
Narrative The goal of the proposed extension and close-out funds is to enable the trial's completion, accomplishment of the previously approved specific aims, and support the close-out activities to fully accrue the returns on NIH's investment in this important trial that has the potential to change clinical practice. This extension of the trial and the associated request for close-out funds had been anticipated for the past 2 years and discussed with the DSMB and the program staff regularly over the course of the past 2 years.